Dynamics of Olfactory Processing: Segmentation in the Piriform Cortex

Abstract
Dynamics of Olfactory Processing: Segmentation in the Piriform Cortex
The proposed research aims to uncover fundamental principles of sensory processing by examining how the
piriform cortex (PCx) in the mammalian brain encodes and represents olfactory information. This work is critical
for advancing our understanding of neural coding, which has broad implications for sensory neuroscience and
can inform approaches to neurological disorders that affect sensory perception and processing. Our study
leverages innovative techniques to record from hundreds of PCx neurons in awake, head-fixed mice while using
optogenetics to stimulate the olfactory bulb (OB) in precise, spatiotemporally defined patterns and manipulate
neural circuits with novel tools to reveal underlying mechanisms. These methods will allow us to test
our overarching hypothesis that the PCx segments incoming OB input into discrete temporal packets within a
respiratory cycle. To this end, we propose the following aims:
Aim 1: Determine the temporal selectivity of PCx responses to OB stimulation. We hypothesize that PCx
neurons jointly encode both OB input and respiration phase. We will test this aim by delivering brief single light
pulses to different dorsal OB spots, aligning stimulation with the respiration phase. We predict that PCx cells are
tuned to respiration phase, showing varying amplitudes but invariant phase preferences across OB inputs.
Aim 2: Investigate the neural circuit mechanisms underlying PCx respiration phase preferences. By
performing various targeted circuit perturbations, we will test the following hypotheses: We hypothesize that
phase tuning is reafferent, that feedback inhibition modulates response gain and sharpens tuning, and recurrent
circuitry redistributes phase preferences to uniformly tile the sniff cycle.
Aim 3: Assess whether PCx responses to odors are phase-locked. Ultimately, we need to test the
hypothesis that PCx responses to odors are segmented and exhibit phase tuning. Therefore, we will (3.1) deliver
multiple odors using 1-sec. odor puffs. Unlike the OB, we hypothesize that cells responding to multiple odors
should show different amplitudes but identical latencies.
Achieving these aims, our research will reveal, characterize, and mechanistically probe a novel framework for
understanding how odor information is encoded in the PCx. This knowledge could eventually lead to novel
strategies for diagnosing and treating sensory processing disorders and enhance our ability to develop artificial
sensory systems.

Public health relevance
Project Narrative The sense of smell plays a crucial role in our quality of life, and its loss (anosmia) – as highlighted by the widespread anosmia associated with Covid-19 – can be not only dangerous but also profoundly impact psychological and emotional well-being. This research aims to fundamentally reframe our understanding of how odor information is encoded in the olfactory cortex. Additionally, since olfactory deficits are linked to neurodegenerative diseases such as Parkinson's and Alzheimer's, understanding these processes in a healthy brain can provide valuable insights into their dysfunction in diseased states.